Using Virtual Reality to help adults with Alcohol Use Disorder learn and practice coping skills in realistic high-risk situations

Project Summary/Abstract
Alcohol use disorders (AUDs) are the third most common mental health condition worldwide and the fourth
leading cause of disability. Only about a third of those with AUD who receive treatment in the US remain
abstinent a year later, suggesting that there is ample room to improve the efficacy of treatment. Helping
patients learn coping skills is a key element of nearly all effective treatments for AUD and could represent a
common factor of these treatments. Coping skills training is also a core component of cognitive behavior
therapy (CBT) for AUD, an evidence-based approach to psychosocial AUD treatment that is commonly used in
community settings. “Coping skills” refer to a broad range of cognitive and behavioral strategies to avoid
drinking, including steps like controlling exposure to high-risk situations, employing various strategies to avoid
drinking in high-risk moments, and assertively refusing social pressure to drink. One common way that
therapists help patients learn these skills is by asking them to anticipate high-risk situations and identify how
they might use specific coping skills in those situations. However, imparting these skills verbally, and in therapy
rooms far removed from the real situations in which patients need to use them, has limitations. Virtual reality
(VR) experiences can provide a way to immerse patients with AUD in realistic high-risk situations to help them
identify important triggers, experiment with different coping strategies, and practice deploying them in realistic
situations. VR has also been used as an adjunct to counseling for a variety of other mental health disorders,
with notable success facilitating exposures for anxiety disorders and PTSD, supporting its feasibility as a tool to
enhance psychotherapy. Meta-analyses suggest that these VR-assisted exposures are realistic and as
effective as in vivo exposures. Several VR experiences that immerse users in situations that are high-risk for
drinking have already been developed, but all have been used exclusively for research purposes. Using
experiences like these to augment treatments that provide training in coping skills could help therapists provide
more realistic contexts that help patients learn and practice these skills, ultimately improving the effectiveness
of these interventions for AUD. In this project, we propose to use the Delphi method to develop consensus
among experts about the most promising ways to use VR to enhance coping skills training and use these
findings to develop a protocol to guide the use of VR within CBT, an evidence-based AUD treatment that
involves coping skills training at its core. In a longitudinal, randomized controlled pilot trial, we will test whether
a 12-week CBT treatment with VR-enhanced coping skills training is feasible, tolerable, and acceptable,
relative to standard CBT in those with AUD. We will also explore preliminary efficacy across conditions and
assess patient and therapist preferences relevant for future implementation. This work is the first step in a line
of research that explores how VR can enhance treatments that are regularly used in community settings.

Public health relevance
Project Narrative This research will explore ways of using virtual reality (VR) experiences that depict high-risk situations for drinking to augment coping skills training as part of evidence-based treatments for alcohol use disorder, such as cognitive behavior therapy (CBT). The project will involve convening a panel of experts in CBT for addictions to identify and prioritize the coping skills that might be best enhanced with VR and test the feasibility, tolerability, and acceptability of CBT enhanced with VR among those with alcohol use disorder (AUD). Accomplishing these aims could enhance the effects of an effective and common treatment and provide a blueprint for how VR might be incorporated into psychosocial treatments for AUD.